FcRn-enabling strategies for improved thrombolytic therapy

PROJECT SUMMARY/ABSTRACT
While clinical use of therapeutic proteins has grown exponentially in recent decades, utility is often limited by
unfavorable pharmacokinetics (PK), mediated by rapid elimination. One approach to overcome this limitation is
half-life extension (HLE), achieved by attachment of biotherapeutics to polymers (PEG), plasma proteins
(albumin, IgG), and blood cells. There is a paucity of data describing the impact of properties of cargo proteins
and HLE-conferring ligands on PK of proteins tested using these strategies. One area where HLE has the
potential to advance clinical therapy is acute, life-threatening, thrombosis (pulmonary embolism, ischemic stroke,
etc.). The only pharmacologic treatment available for treatment of this condition is infusion of plasminogen
activators, which have an unfavorable pharmacologic profile, mediated by a half-life of minutes, rapid inactivation
in plasma, and severe adverse effects (e.g. hemorrhagic transformation). Pilot data demonstrates that
conjugation of a derivative of urokinase selectively activated in thrombin-rich pathological thrombi (scuPA-T) to
an albumin-binding nanobody (Nb) leads to PK that is identical to RBC-binding scuPA-T, an approach pioneered
by Drs. Muzykantov and Cines, albeit with distribution in the plasma rather than the cellular fraction of blood.
The central hypothesis of this proposal is that coupling of scuPA-T to albumin-binding ligands will
provide prolonged circulation, mediated by the neonatal Fc receptor (FcRn), and selective thrombolysis
of pathological thrombi, sparing hemostatic plugs from lysis. In the mentored stage, the impact of
properties of the cargo drug on FcRn-enabled HLE will be identified, using FcRn knockout mice to directly
elucidate the FcRn-mediated component of HLE conferred by albumin binding (Aim 1; K99). Based on pilot
data, safety and efficacy of albumin-binding scuPA-T will be studied in a mouse model of pulmonary embolism.
These results will be used to develop a predictive modeling platform that will be used to for further engineering
and PK optimization of HLE-scuPA-T constructs (Aim 2; K99). With an eye on mechanistic and translational
advancement of this strategy, the role of albumin-binding affinity on the PK of scuPA-T will be defined, using a
newly developed library of nanobodies (Aim 3; R00). Additionally, thrombin-cleavable HLE ligands will be
devised, permitting selective release of scuPA-T in thrombi, improving diffusion into clots and lysis (Aim 3; R00).
Overarching themes of this proposal include identification of critical features of albumin-mediated HLE and
mechanism-based modeling to guide optimization and reengineering of protein therapeutics. A mentoring team
has been identified with expertise spanning the areas of research in this grant, namely, thrombosis and
hemostasis, antibody engineering, and mathematical modeling of biological systems. Mentored research will be
conducted at the University of Pennsylvania, which has a highly collegial and collaborative faculty and extensive
resources available to conduct the proposed research. This proposal is geared towards gaining the expertise
necessary to be successful as a tenured faculty member conducting high quality biomedical research.

Public health relevance
PROJECT NARRATIVE Plasminogen activators are the only approved pharmacologic intervention for acute, life-threatening, thrombotic events, despite unfavorable pharmacokinetics resulting in a poor benefit/risk ratio. In order to solve this longstanding issue, this proposal will apply a novel, physiologically attractive strategy to prolong the circulation of plasminogen activators, namely coupling to albumin-binding ligands to co-opt the endosomal salvage pathway mediated by the neonatal Fc receptor. By delineating mechanisms underlying half-life extension, this research ultimately seeks to not only improve treatment strategies in acute thrombosis, but also guide rational development of pharmacokinetically-optimized protein therapeutics across a range of diseases.